Evaluation of the entero-insular (incretin) axis in cystic fibrosis-competitive renewal.

PROJECT SUMMARY
Cystic fibrosis-related diabetes (CFRD) not only burdens affected patients with a second, attention-demanding
disease but threatens nutritional status, pulmonary function, and survival. Developing strategies to preserve β-
cell function are crucial for interrupting CFRD development and its hazard to CF-relevant outcomes. The overall
aims of this application are to better understand the emergence and progression of abnormal glucose tolerance
in pancreatic insufficient CF (PI-CF) and to test a potential strategy for restoring β-cell function. This application
extends our recent studies demonstrating that 1) insulin secretion defects are present at glucose thresholds
traditionally considered normal (one-hour oral glucose tolerance test [OGTT] glucose >155 but <200 mg/dL;
referred to as early glucose intolerance [EGI]), 2) such subtle glucose abnormalities associate with increased
CFRD risk and may portend greater declines in pulmonary function, and 3) infusion of the incretin hormone,
glucagon-like peptide-1 (GLP-1), but not glucose-dependent insulinotropic polypeptide (GIP), augments glucose-
dependent insulin secretion in PI-CF. Our cross-sectional studies in CF demonstrate marked reductions in meal-
related early-phase insulin secretion and β-cell secretory capacity in EGI. With worsening glucose tolerance, PI-
CF subjects with impaired glucose tolerance (IGT, two-hour OGTT glucose >140 but <200 mg/dL) and CFRD
exhibit further compromised meal-related early-phase insulin secretion and β-cell secretory capacity. The extent
to which emergence and progression of glucose intolerance is a manifestation of worsening β-cell secretory
capacity is not known and will be investigated in longitudinal studies of youth and adults with PI-CF in whom
mixed-meal tolerance tests (MMTT) will be performed to characterize early-phase insulin secretion and glucose-
potentiated arginine (GPA) tests will be completed to quantify β-cell secretory capacity. In Aim 1, we will leverage
the genotyping and clinical phenotyping of our pediatric and adult CF cohort (n=350) to test the impact of T2D
genetic variants, diet, CFTR modulator therapy, and pulmonary exacerbations on the emergence and
progression of glucose intolerance and the relationship of glucose intolerance with nutritional status, pulmonary
function, and body composition longitudinally over 4-5 years. In Aim 2 we will test whether our findings of β-cell
responsiveness to acute GLP-1 infusion has the potential to be translated into the use of chronic GLP-1 therapy
as a mechanism to preserve β-cell function. Specifically, we will pursue a proof-of-concept 6-week randomized,
placebo-controlled cross-over study of the GLP-1 agonist, dulaglutide; the primary outcome will be the impact of
dulaglutide upon meal-related early-phase insulin secretion, one of the earliest defects detected clinically. If
successful, this work will provide the foundation for a multi-center study aimed at identifying and treating early
insulin secretion defects in PI-CF and interrupting progression to CFRD.

Public health relevance
NARRATIVE Diabetes is a major co-morbidity in pancreatic insufficient cystic fibrosis and associated with worse outcomes. While reduced β-cell mass contributes to the insulin deficiency that characterizes cystic fibrosis-related diabetes (CFRD), other modifiable determinants appear operative in the emergence and progression of abnormal glucose tolerance towards diabetes. Identifying 1) the contribution of insulin secretory defects and related modifiable and non-modifiable factors to the emergence and progression of abnormal glucose tolerance and 2) interventions to preserve β-cell function are crucial for delaying and potentially altogether preventing CFRD development.